Utilizing Technology and AI Approaches to Facilitate Independence and Resilience in Older Adults

Detecting Agitation in Persons with AD/ADRD in a Nursing Home Using AI-based Facial Expression
Analysis
ABSTRACT
50% of nursing home residents have moderate or severe cognitive impairment. Persons with advanced
AD/ADRD are often no longer able to communicate verbally. Agitation, which is found in 80% of
residents with AD/ADRD, can pose a major problem for the resident, their family and professional
caregivers. The inability to successfully manage AD/ADRD behaviors, often results in increased burden
on caregivers and use of antipsychotic and other psychotropic medications which may have severe
adverse effects. COVID-19 has also increased agitation incidents among residents with AD/ADRD and
increased distress levels in both residents and caregivers.
In this project we will integrate an AI-based facial expression analysis software with an autonomous
navigating robot and validate that the integrated system can visit nursing home residents with advanced
AD/ADRD and detect agitation.

Public health relevance
Detecting Agitation in Persons with AD/ADRD in a Nursing Home Using AI-based Facial Expression Analysis Public Health Relevance Statement 50% of nursing home residents have moderate or severe cognitive impairment. Persons with advanced Alzheimer’s Disease or Alzheimer’s disease related dementias (AD/ADRD) are often no longer able to communicate verbally. Agitation, which is found in 80% of residents with AD/ADRD, can pose a major problem for the resident, their family and professional caregivers. Patterns of agitation are specific to each person living with AD/ADRD and typically peak times of agitation during the day can be observed. The inability to successfully manage AD/ADRD behaviors, often results in increased burden on caregivers and use of antipsychotic and other psychotropic medications which may have severe adverse effects. COVID-19 has also increased agitation incidents among residents with AD/ADRD and increased distress levels in both residents and caregivers. The way peak agitation is recorded today is through the Agitation and Behavior Measurement Index (ABMI) which requires a staff member to observe a patient every half hour for 13 hours per day, for three days. With the staff shortage (even before COVID-19) it was rarely done. With COVID-19, it is impossible to allocate the staff for doing ABMI for each resident. The proposed system once validated for detecting agitation could become a powerful tool that will enable mapping early signs of agitation and timing nonpharmacological interventions. This in turn could reduce the need for antipsychotic medications and will reduce the stress in nursing home staff and families.